Molecular mechanisms for antiviral signaling and regulation by MDA5 and TRIM65

SUMMARY
MDA5 is a conserved innate immune receptor that detects viral RNAs during infection and activates
antiviral immune response. Recent studies have shown that MDA5 can be activated not only during infection,
but also under various physiological conditions in the absence of infection. Such “sterile” inflammation can
cause pathogenesis of inflammatory disorders, but at the same time, can be therapeutically beneficial, for
example during cancer immunotherapies. Over the last few years, my lab has defined the molecular framework
for understanding how MDA5 recognizes viral dsRNA and activates downstream signaling. We discovered that
MDA5 assembles into filaments upon binding to dsRNA and that the filament formation is required for efficient
dsRNA binding and downstream signal activation. Despite the progress, however, there are key gaps in our
understanding of how MDA5 is activated and how its activity is regulated. That is, what is the exact identity of
dsRNA that stimulates MDA5 both in the virus-infected and sterile inflammatory conditions, and what are the
molecular events following MDA5 filament formation leading up to antiviral signal activation. The goal of this
proposal is to address these two poorly understood aspects of MDA5 function by focusing on TRIM65, a
ubiquitin (Ub) E3 ligase essential for MDA5 signaling.
Previous studies from us and others showed that K63-linked polyUb chains (K63-Ubn) plays an important
role in MDA5-mediated antiviral signaling. TRIM65 has been speculated to be the E3 ligase responsible for the
K63-Ubn conjugation of MDA5. However, whether this is in fact the case, and if so, exactly how and when
TRIM65 acts on MDA5 have been unclear. In our preliminary analysis, we found that TRIM65 directly binds
MDA5, and this binding is strictly dependent on MDA5 filament formation. This observation suggests that
TRIM65 plays a central role as a check-point for ligand discrimination and signal activation. Furthermore, we
found that TRIM65 pull-down can be used for specific isolation of MDA5 filament assembled on agonist
dsRNA, away from the inactive complexes of MDA5 bound to abundant ssRNAs. This finding promises a novel
method for identifying MDA5 ligands, the long-sought-after milestone in the field. Building upon these
progresses, we here propose to address two central questions on MDA5 functions, i.e. signaling mechanism
(Aim 1) and RNA ligand selectivity (Aim 2), from the new perspective of TRIM65. More specifically, we will
determine the structural and biochemical mechanisms by which TRIM65 activates and regulates MDA5 (Aim 1)
and develop a novel TRIM65 pull-down strategy to identify the RNA ligands for MDA5.
We believe that the proposed work would demonstrate how an E3 ligase can directly participate in the self
vs. non-self discrimination and immune signaling processes, and would provide a model for investigating other
E3 ligases in immune functions and beyond. Furthermore, our research may also guide new therapeutic
strategies to target MDA5 functions and its antiviral signaling pathway.

Public health relevance
Public Health Statement Viral infection poses a major challenge to global health as demonstrated in the recent pandemics of H1N1 influenza virus, SARS and HIV. The goal of the current proposal is to understand the molecular mechanisms of viral recognition and regulation by MDA5 and TRIM65, which together constitute one of the principle innate immune pathways. These signaling pathways have been also implicated in pathogenesis of several autoimmune and inflammatory diseases, and were proposed to be a potential therapeutic target in anticancer immunotherapies.